Core C - Modeling Core

01. PROJECT SUMMARY
Influenza infection leads to different clinical outcomes that range from benign symptoms to hospitalization and
sometimes death (ranging from 12,000 to 56,000 deaths per year in the United States). However, biomarkers
predictive of influenza disease outcomes (i.e. symptoms severity, viral replication) which are key for preventive
medicine have not yet been identified. Moreover, elucidation of the molecular components that govern predictive
signatures will provide important clues that will guide the development of novel therapeutic strategies. This U19
will build on a wealth of data gathered already by the previous FluOMICS consortium and pursue two converging
hypotheses 1) multiple and discrete host immune response pathways act in concert to determine the pathogenic
outcome of influenza infection 2) the crosstalk between influenza and these host pathways results in the
establishment of correlated epigenetic, transcriptional, post-translational, metabolic signatures in multiple tissues
and cell types. The major objective of the Modeling Core will be to use network-based modeling approaches to
integrate the experimental data generated by Project 1 and Project 2, identify biological processes that can
predict influenza disease outcomes and validate them functionally in collaboration with Project 1 and Project 2.
In Aim 1 the Modeling Core, in collaboration with the Technology Core and the Data Management and
Bioinformatics Core, will preprocess, apply the appropriate statistical analysis and interpret all large-scale
(OMIC) datasets generated in Project 1 and Project 2. We will provide data integration and visual representation
for each OMIC dataset and summary tables giving the number and identity of differentially expressed markers
(genes/proteins/post-translational modifications/metabolites) associated with disease outcomes. In Aim 2, the
Modeling Core will provide an integrated view of all these datasets by mapping them to networks of transcriptional
nodes and signal transduction pathways which are differentially triggered by different conditions of infection and
mimic differences between hosts. Critically, the Modeling Core will apply heuristic approaches and an iterative
process with the Project 1 and Project 2 to unravel and improve on correlations between networks of biological
pathways collected in orthogonal sample types (i.e. human/mouse blood, mouse lungs, and human cells)
generated by the cores. In Aim 3 the Modeling Core will use a machine learning technique to generate predictive
models based on prioritized set of markers able to predict responses to influenza strains linked to various disease
states. These markers will include host factors and host-pathogen interactions that predict clinical outcomes and
may be mechanistically implicated in symptoms severity. The Modeling Core will stand in this U19 as the ultimate
infrastructure and resource that will integrate the large body of data generated in this program and provide to the
scientific community important deliverables namely validated signatures of disease severity, biomarkers for
preventive medicine and mechanistic cues to the diversity of clinical outcomes.!